Pathomechanisms of SCN3A-related neurodevelopmental disorder

PROJECT SUMMARY
Recently-described SCN3A-related neurodevelopmental disorder (SCN3A-NDD) is caused by pathogenic
variants in the gene SCN3A, which encodes the sodium (Na+) channel subunit Nav1.3. SCN3A-NDD is a
devastating condition defined by treatment-resistant epilepsy and severe/profound intellectual disability (ID);
surprisingly, many patients also exhibit malformation of cortical development (MCD), a developmental
disturbance in the structural formation of the cerebral cortex of the brain, suggesting functional roles for Nav1.3
during embryological development. How genetic variants in SCN3A leads to epilepsy and neurodevelopmental
disability, and how SCN3A variants lead to MCD, is unknown. Research is required to clarify the functional role
of Nav1.3 during early brain development and to progress towards novel therapies or preventative measures
for SCN3A-NDD, which is currently and untreatable disorder.
This 5-year collaborative application employs novel tools and innovative neuroscience approaches to test the
hypothesis that pathogenic variants in SCN3A lead to a disorder that includes epilepsy and MCD via
dysregulated Na+ currents in migrating neurons of the developing cerebral cortex.
Electrophysiological recordings in heterologous cell systems indicate that pathogenic SCN3A variants found in
patients with SCN3A-NDD largely produce Na+ channels that exhibit gain of function due to increased
persistent current and alterations in the voltage dependence of channel activation, which increase channel
activity. However, the mechanistic basis of observed variability in epilepsy severity and presence or absence of
MCD, is unclear. And how altered channel activity impacts the function of neurons has not been investigated.
Proposed experiments will determine the relationship between specific SCN3A variants and correlated clinical
phenotype (epilepsy, MCD, severity of ID) in a large cohort of human patients with SCN3A-NDD. To link
SCN3A variants to dysfunction of ion channels and neurons, we will compare the biophysical properties of
normal Na+ channels to channels containing variant Nav1.3; test cell-intrinsic effects of SCN3A variants in
neurons generated from induced pluripotent stem cells from human SCN3A-NDD patients; and test effects of
variant overexpression via in utero electroporation of mouse embryo followed by electrical recording in brain
slices (Aim 1). The impact of variant SCN3A on the morphology of immature neurons and cytoarchitecture of
the developing cerebral cortex will inform the role of SCN3A in development (Aim 2). To translate these
findings towards clinical applications, we will attempt to ameliorate features of SCN3A-NND in advanced model
systems, including a newly generated conditional point mutant mouse, via targeted manipulation of pathogenic
Nav1.3-mediated Na+ current (Aim 3).
Results will provide novel information on the role of Nav1.3 during brain development, and will define the
pathogenic mechanisms of SCN3A-NDD towards development of novel, targeted therapies in human patients.

Public health relevance
PROJECT NARRATIVE SCN3A neurodevelopmental disorder is a devastating condition caused by mutation of the gene SCN3A (which encodes the sodium channel subunit Nav1.3) and is defined by treatment-resistant epilepsy, severe/profound intellectual disability, and malformation of cortical development, the latter being a surprising consequence of dysfunction of an ion channel. The objective of this proposal, which employs cutting-edge tools and innovative technical approaches in newly-generated advanced model systems, is to investigate the pathogenic mechanisms that underlie epilepsy and brain malformation in SCN3A neurodevelopmental disorder. The long- term objective of this research is to (1) understand the normal role of Nav1.3 in the function of developing neurons and (2) advance from preclinical models to mechanistically oriented treatments or preventative therapies in human patients.